Synthetic Biology and Biotechnology (SB2) Predoctoral Training Program

Project Summary/Abstract
Synthetic biology uses biological ‘building blocks’ to create fundamentally new biological systems,
capabilities, and behaviors. This fast-growing discipline has the potential to revolutionize many scientific fields
and industries, including biotechnology, agricultural technology, microbial ecology, cellular agriculture and plant-
based meats, biomanufacturing, and medicine. Efforts are needed to formalize the theory, practices, and
standards in synthetic biology so that future Ph.D. graduates can develop new synthetic biological methods and
implement them to address a broad range of scientific problems. Synthetic biology is, by nature, an
interdisciplinary enterprise, forged between biology, engineering, chemistry, and physics. As such, it also
represents an ideal discipline around which to build a training paradigm that incorporates team science,
interdisciplinary thinking, communication, and business understanding.
This proposal seeks five years of support to enhance and improve an established predoctoral training
program in Synthetic Biology and Biotechnology (SB2) at Boston University, which accepts students from the
Department of Biomedical Engineering, the Bioinformatics Program, and the Molecular Biology, Cell Biology, &
Biochemistry Program. We are requesting support for eight predoctoral trainees per year for all five years of the
Training Program; we will use these funds to support four Ph.D. student trainees for 24 months, during the second
and third years of their graduate degree. BU will provide support for an additional two trainees per year, for all
five years of the Training Program. This means that our Training Program will support 12 total trainees across
two cohorts: six second-year Ph.D. students and six third-year Ph.D. students. Our 26 faculty mentors are drawn
from various departments and colleges at Boston University, with expertise in engineering, molecular and cell
biology, pharmacology, chemistry, computational biology, physics, microbiology and evolution, and other related
fields. To promote rigorous training in transdisciplinary research and teamwork, all SB2 trainees will be co-
mentored by two of these faculty members: the primary mentor will act as a traditional Ph.D. supervisor, and the
secondary mentor will provide additional research expertise and support.
In addition to building a field-defining synthetic biology curriculum that includes technical training, mastery
of computational and data analysis methods, and critical thinking skills, we will enhance the professional
development skills our trainees require to succeed in this highly interdisciplinary field and give them opportunities
to interact with the vibrant biotech community in Boston, which is already being transformed by this field.
Numerous mechanisms will be employed to assist trainees in preparing for diverse career paths with formal and
informal opportunities to learn from STEM professionals from a range of careers. Through this program, we will
train these synthetic biologists to drive this field forward and become the next generation of leaders in this
interdisciplinary and transformative science.

Public health relevance
Project Narrative Synthetic biology is a fast-growing discipline that aims to re-engineer cells and other biological systems to solve critical challenges in human health and the environment. Graduate students participating in this training program will learn the principles and practices of how to engineer biology, gain unique exposure to the biotechnology landscape in Boston, and obtain the professional skills necessary for success in interdisciplinary research. They will play vital roles in advancing this discipline and delivering on the promise of synthetic biology to revolutionize biotechnology.